Multipurpose Upright Optical Microscope for Imaging Core

Abstract
Funds are requested to acquire a Zeiss LSM 900 fluorescence confocal microscope to support the research
efforts of multiple NIH-funded investigators at the Virginia Commonwealth University (VCU). The microscope will
meet increasing demand multicolor 3D imaging of cell cultures and tissue samples in automated manner.
Numerous research questions, developed in recent years, require visualization of these specimens at multiple
scales, from cell population down to subcellular structures (vesicles, endoplasmic reticulum tubules, cytoskeletal
filaments). None of the microscopes currently available at VCU (confocal or structured illumination) have the
combination of imaging speed, ease of magnification changes and ergonomic operation, needed to execute
these tasks robustly for large number of samples. The requested Zeiss system is configured around an Axio
Imager Z2 upright stand and equipped with a motorized (piezo) stage with a 4-slide holder. The microscope has
3 high-sensitivity fluorescence confocal detectors, a transmitted light detector and a color camera for wide-field
imaging. These features will make the LSM 900 a significant upgrade of the only upright VCU confocal
microscope, Zeiss LSM 700 and its wide-field counterpart, Zeiss/MBF Neurolucida. The former system has
experienced heavy usage since its installation in 2013. However, performance of the LSM 700 no longer meets
requirements of contemporary experimental protocols and its further maintenance no longer guaranteed by the
manufacturer (Zeiss). The new system will be housed in a well-established and highly productive Microscopy
Shared Resource (MSR) facility. MSR is directed by the PI, who has expertise in multiple aspects of microscopic
imaging. During the past five years (2019 - 2023), 135 different laboratories, representing 312 investigators from
17 different departments at VCU have used the MSR and its services (widefield fluorescence, confocal, TIRF,
SIM, electron microscopy, image analysis, and sample preparation). The projects conducted by these
researchers represent a broad range of studies (cell biology, microbiology, neurobiology, bioengineering,
virology, pharmacology, physiology, etc.). Representative studies of major users (from 12 labs; 5 departments)
and minor users (from 3 labs; 2 departments), who are funded by NIH, have been highlighted in this proposal.
Acquisition of a versatile confocal/wide-field microscope will have a major impact on research at VCU as it will
preserve and expand the capacity of a well-used core facility and attract additional users (whose needs cannot
be met by the equipment available at VCU).

Public health relevance
Narrative Acquisition of the multipurpose optical microscope will facilitate NIH-funded research for a large number of investigators at Virginia Commonwealth University. This system will provide automated multicolor 3D imaging with high resolution and speed to address biological mechanisms underlying variety of diseases. Projects described in this proposal include studies related to: myelin formation (and myelin defects in multiple sclerosis), molecular mechanisms involved in neural damage and repair following traumatic brain injury, the role of microglia in neurodegenerative diseases such as Alzheimer’s and Parkinson’s disease, epithelial cell homeostasis (affecting permeability and cancer progression), the molecular mechanisms and consequences by which drug abuse alters CNS organization and function in individuals infected with HIV-1, functioning of brain serotonin receptors and their role in depressive disorders, the regulatory mechanisms of vesicular trafficking in podocytes (which plays a role in glomerular disorders such as minimal change disease, diffuse mesangial sclerosis, focal segmental glomerulosclerosis, obesity, and diabetes), initiation and progression of tumors in a hepatocarcinoma model, regulation of ceramide synthesis (involved in the response of cancer cells to chemotherapy), metabolism of sphingolipids (implicated in Niemann-Pick Type C disease, cholesterol disorders, cancer, and Parkinson's disease), mechanisms of axonal degeneration relevant to CNS inflammatory disorders such as multiple sclerosis, protein trafficking in cardiac myocytes and its role in heart failure.